Intracranial Neurophysiological Signatures of Fear and Anxiety in Humans

Project Summary/Abstract
Accumulating evidence from studies in rodents suggests that emotional reactions to threatening stimuli rely on
neurophysiological changes within an anxiety-processing network that includes the medial prefrontal cortex
(mPFC), basolateral amygdala (BLA), and ventral hippocampus (vHPC) [1]. Since rodent studies often use
laboratory animal models (similar to healthy humans) it is unclear whether findings will translate to the human
mPFC-BLA-vHPC network especially in individuals with various levels of anxiety such as post-traumatic stress
disorder (PTSD) or generalized anxiety disorder (GAD). The proposed project will implement a first-of-its-kind
platform for intracranial electroencephalographic (iEEG) recording and intracranial electrical stimulation (iES) of
mPFC-BLA-vHPC oscillatory activity during laboratory and naturalistic fear-based tasks using immersive virtual
reality (VR) technology and wearable biometric sensors capable of recording physiology (eye-blinks, heart rate
variability [HRV], skin conductance response [SCR], and pupil size). Through an interdisciplinary collaboration
between UCLA and the Veteran’s Administration Greater Los Angeles Healthcare System (VAGLAHS) the
proposed project will have access to 80 epilepsy participants implanted with mPFC, BLA, and/or vHPC depth
electrodes with varying levels of dysregulatory anxiety-related processing. Since our studies address basic
questions about the role of mPFC-BLA-vHPC oscillations in human fear and anxiety, the results will bridge
findings across species and lay the scientific foundation for helping future patients with debilitating anxiety
disorders.

Public health relevance
Project Narrative Anxiety disorders such as post-traumatic stress disorder (PTSD) and generalized anxiety disorder (GAD) affect a large number of individuals with a significant portion of patients failing to improve with current treatments. The proposed project will provide first insight into the intracranial neurophysiological signatures of fear and anxiety in patients with varying levels of dysfunction and/or dysregulation of arousal and negative valence systems. Findings will address questions about the relationship between intracranial neurophysiological activity, neurostimulation, and physiological responses during fear-related states and help lay the foundation for future treatments for illnesses marked by debilitating anxiety.